AI-powered chemical proteomics for drug discovery targeting orphan proteins

Abstract
Genome-Wide Association Studies, whole-genome sequencing, and high-throughput techniques have
generated vast amounts of diverse omics data. However, these sets of data have not yet been fully explored to
improve the effectiveness and efficiency of drug discovery. Only 5-10% of druggable proteins are targeted by
pharmaceuticals. The undrugged proteins are potential targets of yet-incurable diseases but they remain dark,
i.e., their endogenous and exogeneous small molecule ligands (chemicals) are unknown. Furthermore, there is
a knowledge gap to link drug-target binding affinities to clinical outcomes. We know little if the target is activated
or inhibited by the binder (i.e., function activity: agonist vs. antagonist). To date, few experimental and
computational tools can determine genome-wide protein-chemical interactions (PCIs) for dark proteins and
ligand-induced functional activities (LIFAs) for majority of proteins including both dark and well-studied proteins.
Existing machine learning techniques is unsuccessful in exploring the dark protein space due to an out-of-
distribution (OOD) problem, i.e., they cannot reliably predict the function of an unseen protein or chemical if it is
significantly different from proteins or chemicals in the training data, respectively. Commonly used computational
tools for structure-based drug design, such as protein-ligand docking/scoring and Molecular Dynamics
simulations, are neither scalable nor particularly reliable. As a result, we only have a limited capability of
compound screening and lead optimization between novel chemicals and dark proteins. This proposal seeks to
develop and experimentally validate innovative methods for illuminating the molecular function of dark proteins
and apply them to drug discovery for presently incurable diseases. Building on our successful proof-of-concept
studies and our close multidisciplinary collaborations between experimental and computational laboratories, we
will develop a novel computational framework to model drug actions on a multi-scale by integrating big data from
chemical genomics, functional genomics, and structural genomics and developing innovative deep learning
algorithms. Specifically, we will develop a structure-enhanced deep learning framework to reliably and accurately
predict the binding affinity of novel small molecule ligands to dark proteins on a genome-scale. We will integrate
functional genomics with chemical genomics to predict ligand-induced functional activity. We will apply the
methods developed to design and experimentally test inhibitors of dark anti-cancer target AVIL and selective
dual antagonists of dopamine receptors for opioid use disorder (OUD). The proposed research offers an
innovative concept, methodology, and translational applications. Completing this research will fill a critical
knowledge gap in understanding drug actions in a biological system and significantly impact drug discovery for
complex diseases, many of which lack effective and safe treatments. The developed methodology and platform
will not only immediately impact the NIH’s “Illuminating the Druggable Genome” Program but also has potentially
broad applications in other areas of biomedical research.

Public health relevance
Relevance Statement The unmet need in the treatment of cancers and Opioid Use Disorders (OUD) poses a great threat to human health and welfare. The conventional drug discovery process has yielded very few successes. New approaches are needed to reduce the time and cost in drug discovery and development. We propose a novel machine learning powered systems pharmacology approach to accelerate drug discovery and development.